METHYLPHENIDATE IN MALE RHESUS MONKEY

A study to evaluate the growth and pubertal development in male rhesus monkeys chronically exposed to methylphenidate. One of the more commonly recognized pediatric behavioral disorders is Attention Deficit Hyperactivity Disorder or ADHD, in which methylphenidate is drug for treatment.